Investigation into neural and muscular components of breathing in Down Syndrome

This section is not a required component of the application.

Public health relevance
This section is not a required component of the application.